MAITEC FOR PATIENTS WITH MULTI-DRUG RESISTANT TUBERCULOSIS AND AIDS

The purpose of this trial is to assess the safety the safety of liposome encapsulated gentamycin (Maitec) in the treatment of AIDS patients who have multi-drug resistant tuberculosis in combination with three second- line anti-tuberculosis drugs. The lab was used for ELISA and BAL analysis.